EPIDEMIOLOGY OF DIABETES INTERVENTION AND COMPLICATIONS

The Epidemiology of Diabetes Intervention and Complications (EDIC) is in its sixth year (out of 10). The purpose is to determine if intensive insulin therapy in people with Type I diabetes can prevent or delay diabetic complications (both microvascular and macrovascular). No preliminary findings have been revealed to date.